Integration of HSC Stress Responses and Disease Progression by DNMT3A Mutations

ABSTRACT
In this Pathway to Independence Award application, Dr. Christine (Ruochao) Zhang outlines detailed career
developmental plans to strategically enhance her knowledge in trending hematology and her expertise of state-
of-the-art techniques while interrogating how Dnmt3a mutations endow hematopoietic stem cells (HSC) a fitness
advantage during chronic inflammation and prime defective hematopoiesis for disease progression.
Dr. Zhang is a postdoctoral research associate at the Washington University School of Medicine and has a strong
background in epigenetics and genetics with a diverse range of technical skills. Herein, she wants to understand
how epigenetic perturbations lead to defective hematopoiesis and consequently blood diseases. The primary
goal of Dr. Zhang is to become an independent investigator in epigenetic hematology. Dr. Zhang has proposed
career development plans, where she will be rigorously trained with highly successful, world-renowned leaders
in hematology, including hematopoietic stem and progenitor cell (HSPC) biology (Dr. Grant Challen), bone
marrow niche and pathology (Dr. Daniel Link), and disease hematopoiesis (Dr. Timothy Ley). Her outstanding
mentor team will ensure her success in reaching this ambitious goal. Dr. Zhang will gain 1) strengthened
knowledge in HSPC biology, bone marrow composition, and hematologic disease pathology; 2) expertise in
advanced epigenetic analysis at the single-cell level and in multiplex imaging analysis; 3) critical soft skills
required for running a successful and innovative independent laboratory.
Somatic mutations in DNA methyltransferase 3A (DNMT3A) acquired in the HSC compartment during aging give
rise to clonal hematopoiesis (CH), a condition associated with increased risks of hematologic diseases. The
disproportional prevalence between DNMT3A-CH (10%) and blood diseases (~1%) suggests environmental
pressures are likely required for clonal selection and evolution for disease progression. While cumulative
evidence has suggested that DNMT3A mutations can be selected by chronic interferon-gamma (IFNg) signaling,
it remains elusive how DNMT3A mutations confer a fitness advantage to HSCs during chronic inflammation; how
the expansion of Dnmt3a-mutant HSCs reshapes the bone marrow composition and ultimately leading to disease
conditions. The goal of this study is to interrogate the mechanism(s) underlying the HSC fitness advantage
conveyed by Dnmt3a mutations and to understand how the defective hematopoiesis selected by chronic
inflammation gives rise to disease conditions at least in part attributed to bone marrow remodeling.
The overarching goal of this proposal is to develop Dr. Zhang into a successful independent investigator in
epigenetic hematology. The knowledge and experience acquired from the proposed studies and the career
development plan will firmly set her on the path to becoming a leading investigator of epigenetic hematology.

Public health relevance
PROJECT NARRATIVE Defective hematopoiesis is a hallmark of blood diseases, many of which are enriched with Dnmt3a mutations and are associated with an enhanced inflammatory milieu. This project will generate an improved understanding of the mechanism(s) by which Dnmt3a mutations endow a fitness advantage to hematopoietic stem cells (HSCs) during chronic inflammation, which remodels bone marrow composition and reinforces further selections of the mutant HSCs for disease progression. Results generated from this study will likely lead to therapeutic opportunities that allow early interventions of DNMT3A-mutant clonal hematopoiesis-associated blood diseases.